Molecular determinants of high seizure risk times

Epilepsy is the third most prevalent neurological disorder after stroke and Alzheimer’s Disease with an incidence
of 1 in 26 individuals. It is estimated that 3 million people in the U.S and 65 million worldwide currently live with
epilepsy. Approximately 30% of epilepsy patients are drug resistant and this number has remained the same
since 1850 despite the marketing of 12 new antiseizure drugs in the past 20 years. A major hurdle to
understanding the disease is that seizures are transient and importantly, difficult to predict. This prevents the
acquisition of a detailed portrait of molecular, cellular and circuit alterations at the most critical time: just before
seizure onset. However, seizures manifest a clear temporal organization: they display circadian and multi day
(mulitdien) rhythmicity in patients, regardless of epilepsy type or affected brain region. Combining circadian and
multidien rhythms, one can extract high seizure risk (HiSR) and low seizure risk (LoSR) epochs in a patient-
specific manner. Importantly, this cyclicity in risk exists in two rat models of epilepsy and canine epilepsy. The
existence of HiSR and LoSR times imply that circuit excitability changes in a periodic manner that can be
modelled and predicted, and its mechanisms studied. We have developed a machine learning tool that acquires
continuous EEG over many weeks, learns the pattern of interictal activity and then predicts when an animal is
entering a LoSR or HiSR epoch. The goal of this application is to embark on the first ever global molecular
and cellular exploration of HiSR and LoSR epochs. Historically, a common research strategy has been to
compare non-epileptic to epileptic brains and, clearly this approach has yielded a wealth of knowledge regarding
mechanisms behind seizure genesis and epileptogenesis. The premise of our application is that epileptic and
non-epileptic brains are different enough from each other that additional, unique insights will be uncovered by
using LoSR epochs as controls for HiSR epochs. Preliminary data from bulk tissue shows a differential
expression of nearly 100 hippocampal proteins between HiSR and LoSR times. Together, these findings inform
our central hypothesis that large scale hippocampal gene changes, driven by a few Master regulators,
contribute to alterations in seizure risk over the multidien cycle. We will perform single cell RNAseq on
hippocampi from rats in LoSR and HiSR to generate a high resolution, single cell map of all gene changes that
occur as a brain transitions from a low to high seizure risk state.
To the best of our knowledge this will be the first ever study comparing molecular and electrophysiological
changes at the single cell level in the epileptic brain as it transitions from a low to a high seizure risk state. Using
bioinformatic tools developed and published by us, we will identify potential Master Regulators behind these
changes in every cell type and subfield of the rat hippocampus. The major deliverable of the proposal will be a
detailed cell type specific transcriptome map accompanied by a survey of network properties during HiSR and
LoSR epochs

Public health relevance
NARRATIVE Epilepsy afflicts 1% of the population and is characterized by spontaneous seizures. About 30% of patients do not respond to current therapies. Thus a deeper understanding of the mechanisms that drive the disease are required. We have constructed a machine learning algorithm that can predict when a rat brain is about to enter a zone of high seizure risk. By analyzing rat brains as they transition from epochs of low seizure risk to high risk, we will uncover the molecular, cellular and network changes that push brains to the edge of a seizure. We will perform single cell sequencing and cellular recordings from brains that are in low and high seizure risk states.